Integrated Exchange and Storage of Current- and Future-Generation Immunogenomic Data

PROJECT SUMMARY
The Human Leukocyte Antigen (HLA) region on human chromosome 6p21 is the most medically important region
of the human genome. Over 100 infectious, autoimmune and pharmacological disease phenotypes and cancers
are associated with genetic variation of HLA, and matching of HLA genotypes is required for bone marrow and
solid organ transplantation. HLA molecules have functional interactions with Killer cell Immunoglobulin-like
Receptor (KIR) molecules, also recognized to play critical roles in transplantation and disease. The genes
encoding these molecules are highly polymorphic and display extensive structural variation relative to other
genomic regions. Recognizing the need to consolidate complex data from a broad field, in the prior project
periods we developed a suite of tools and programs for the standardized analysis, collection, exchange and
storage (ACES) of all current and future immunogenomic data. These tools serve to fill gaps in genomic data-
management and analysis tools, which are primarily designed for use with single nucleotide polymorphism (SNP)
and whole-genome and whole-exome sequence (WG/ES) data, and do not support the highly polymorphic
genetic data characterized by the immunogenomic loci and other highly polymorphic genetic systems. Our
standards and tools have been widely adopted by the immunogenomics community, but there remains an urgent
and unmet need for integrated, easy-to use, clinical-grade tools that unify immunogenomic genotype, SNP and
WG/ES data, while anticipating future genomic data formats. In the previous project periods, we have made
substantial progress on the development of these tools and resources, which are designed to maximize the
ongoing utility of immunogenomic data for clinical and basic research science. In the proposed project period,
we will advance the development of these tools, expanding their scope and improving ease of use, centralizing
their availability and enabling interoperability with electronic medical record (EMR) systems, and making them
available adjacent to these highly complex datasets for application in translational medicine. We will expand the
utility of our tools and services to accommodate additional data types and analytical methods, as well as
integrating across methods. Building on our development of an infrastructure to support transmission of HLA
data using HL7 FHIR resources, we will work to incorporate these resources into our data management tools
and pipeline. Finally, we will build on an infrastructure developed to support aggregation and standardized
analysis of HLA data in the context of COVID-19 to support additional data types and disease phenotypes for
immunogenomic disease association studies. By integrating these resources, and other tools and services we
have developed, and empowering them to generate FHIR messages, the products of these immunogenomic
ACES resources can be made available and accessible to researchers and within health systems, improving our
understanding of immunogenomics in human health and facilitating application for translational medicine.

Public health relevance
PROJECT NARRATIVE The Human Leukocyte Antigen (HLA) and Killer-cell Immunoglobulin-like Receptor (KIR) genes are highly complex and varied when compared to the rest of the human genome, but are central for understanding the genetic basis of disease and for improving human health. The system of tools, standards and services that we are building will maximize the use of current and future forms of data for the HLA and KIR genes, facilitating clinical therapies and giving clinicians easier access to research findings. The expanded HLA|COVID-19 Database will serve as a community resource for studying the relationship of HLA and KIR gene variants with many human diseases.